Pan-lyssavirus therapeutics and mechanisms of protection against lyssaviruses

Abstract
Rabies disease is nearly 100% lethal in the absence of treatment, killing an estimated 59,000 people annually.
When vaccines are properly administered, they are highly efficacious, making them one of the most economically
high-impact interventions among infectious diseases. About 30,000 people receive post-exposure treatment in
the USA annually indicating the need for treatment options against RABV. Of note, fifteen rabies-related viruses
(lyssaviruses) are similarly lethal, but divergent enough to evade protection from current vaccines and biologics,
which are based on the classical rabies virus (RABV).
We previously designed a structurally-informed chimeric glycoprotein (G) to incorporate large ectodomain
regions of two divergent lyssaviruses, RABV and Mokola virus (MOKV). In vivo, this vaccine elicited neutralizing
antibodies against both RABV and MOKV and protected against challenge with viruses containing MOK G or
RABV G. Based on knowledge of the RABV G, these preliminary data suggest that i) the chimeric G includes
important antigenic regions from both RABV and MOKV and that ii) the elicited antibodies should protect against
challenge. Moreover, some data also raised the compelling suggestion that antibody mechanisms in addition to
neutralization may contribute to protection.
Three independent but complementary aims are proposed to take the discoveries of the R21 to the next level.
The first Aim will investigate the immunogenicity and protective quality of a chimeric G lyssavirus vaccine against
a panel of different lyssaviruses of importance. Aim 2 examines antigenic regions of non-RABV lyssavirus
glycoproteins (G) and delineate the antigenic regions on the lyssavirus Gs by isolating and characterizing
neutralizing monoclonal antibodies (mAbs). The dogma for protection against RABV is that neutralizing
antibodies are necessary and sufficient. This has not been studies for non-RABV lyssaviruses and is not
completely supported by preliminary data from our previous study. Therefore, Aim 3 will revisit the mechanism
of protection against Lyssaviruses in pre- and post-exposure applications and redefine the function of
neutralizing and non-neutralizing antibodies for protection from rabies.

Public health relevance
Narrative There are sixteen viruses similar to the rabies virus which cause rabies disease but which are genetically different enough that the current rabies virus vaccine is not projective. This grant application proposes to develop a new generation of more broadly efficient vaccines and antibodies, which will protect against rabies disease independent of the virus causing it.